Biostatistics for Research in Environmental Health

This is a competing renewal application for the UNIversity of North Carolina-Chapel Hill T32 in Biostatistics for
Research in Environmental Health (UNITE T32). Our unique program integrates strengths in environmental
health sciences and engineering (ENVR), environmental epidemiology (ENVR-EPID), and environmental
biostatistics (ENVR-BIOS) to provide students with cutting-edge training and methodological skills necessary to
leverage next-generation tools, tackle emerging environmental health threats, and accelerate scientific
discovery. We provide outstanding didactic training for predoctoral and postdoctoral scholars, equip trainees with
critical data science skills, offer opportunities for impactful and innovative environmental health research and
North Carolina-based community engagement, and advance the environmental health sciences workforce
pipeline. Our training program places particular emphasis in three thematic areas: (1) data science for
environmental public health; (2) emerging contaminants due to changing climate and consumer products; and
(3) environmental justice. These areas of emphasis provide synergy across departments and enrich the training
experience by informing professional development opportunities, engaging external collaborators for
interdisciplinary trainee research, and promoting relevant scientific seminars and journal club offerings. The
UNITE T32 is situated within the interdisciplinary research environment of the Gillings School of Global Public
Health at UNC Chapel Hill (UNC SPH), which ranks 2nd among schools of Public Health in the nation and #1
among public schools of Public Health. The UNC SPH houses the NIEHS-funded Center for Environmental
Health and Susceptibility and Superfund Research Program, as well as multiple other environmentally-focused
research centers and institutes. Training faculty at UNC have over $37M in environmentally-focused research
funding and lead core facilities that provide opportunities for trainees to establish proficiency in a wide range of
methodologies. UNC institutional commitment is strong, with $2,644,000 in funds for faculty start-ups, MPI effort,
and administrative support. The UNITE T32 includes 45 outstanding environment health sciences mentors, with
exceptional track records of research spanning diverse interest areas. Selection of pre- and postdoctoral trainees
for the UNITE T32 is based on academic success, strength of the proposed research, relevance of the research
to Program goals, and commitment to environmental health sciences. Trainees attend professional development
workshops and obtain specialized training in rigorous research methodology, research ethics, and proposal
development, with opportunities to present their research to local, national and international audiences. This
application requests support to allow 23 predoctoral and 5 postdoctoral trainees across three departments to
become leaders in the field of environmental health research, thus supporting global efforts to reduce the
environmental impact on human health. The successful track record of the UNITE T32 justifies this investment,
with former trainees in premier academic, government, industry and non-profit positions.

Public health relevance
This UNITE T32 training program at UNC Chapel Hill supports trainee development of those working at the interface of environmental biostatistics, environmental epidemiology and environmental health. The trainees develop critical thinking skills and learn how to use state-of-the-art methodologies to address urgent and critical needs in environmental health sciences as they arise. Our transdisciplinary approaches focus on: (1) cutting edge data science for environmental public health, (2) emerging contaminants due to changing climate and consumer products that threaten North Carolina and the world, and (3) environmental justice.